Community Development and Education Core

The Duke Multiscale Immune Systems Modeling Center of Excellence (CoE) Community Development and
Education Core (CDEC) is designed to unite and support the community of infectious and immune-mediated
diseases (IID) modelers, both within the CoE and in the broader IID modeling community. The CDEC will serve
as a central hub for mentorship, training, and collaboration, with particular focus on supporting the needs of
early-stage investigators (ESI) and investigators new to multiscale modeling research to foster the next
generation of transdisciplinary biomedical and quantitative scientists. The CDEC will provide much needed
educational and mentoring activities for students, postdoctoral fellows, ESI and investigators from diverse
communities through achievement of the following aims: (1) Develop a Community of Learning to provide
mentorship and training for ESI interested in modeling IID across biological scales; (2) Develop a Community
of Practice to support and enhance collaboration, research development, and mentoring opportunities for IID
modelers; and (3) Organize an annual conference to unite the modeling community, sharing experiences,
technologies, and methods, and fostering collaborations with NIAID programs and staff. To establish the
Community of Learning, the CDEC will leverage the rich research and mentoring support already existing at
Duke, and tailor new offerings focused on building institutional, regional, and national capacity for research to
advance and integrate models across biological scales for infectious diseases. The CDEC will also offer two new
scholar programs to develop graduate students and postdoctoral fellows respectively and provide professional
development and team science training coordinated with the Demonstrative Core. To establish the Community
of Practice, the CDEC will build the infrastructure to support the IID Modeler Network (IIDMN), based on the
highly successful University of Michigan Applied Biostatistical Sciences (ABS) network building framework. The
CDEC will also develop opportunities for IID community collaboration, such as the monthly multiscale modeling
webinar, and networking events at the Annual Meeting. The Annual Conference organized by the CDEC will also
be an avenue to disseminate the infrastructure, tools, and models developed by the CoE, and establish new
collaborative working groups with other NIAID modeling groups. The CDEC will have transdisciplinary multi-
principal investigator leadership and will include a Steering Committee comprised of ESI with complementary
expertise in computational and experimental sciences. The proposed program will implement proven and
innovative strategies to improve training, connections, and workforce development opportunities for researchers
across the country. The CDEC’s efforts will focus on building successful trans-disciplinary communication and
team science collaboration and will significantly contribute to the COE’s mission by providing an enriched
environment for innovative research and promoting the growth of ESI and investigators new to IID multi-scale
modeling.